Accelerating Health Information Resource Equity for Multiracial Populations

ABSTRACT
The goal of this proposal “Accelerating Health Information Resource Equity for Multiracial Populations” is to
harness the methods of library and information science, health disparities, and informatics research to improve
access to and increase dissemination of information resources on CVD risk for Puerto Ricans, a multiracial
disparity population. Puerto Ricans face unique risk factors as a result of their African, indigenous, and
European ancestry; have high rates of CVD risk factors, such as smoking, hypertension, and diabetes; and
experience poor treatment outcomes. We plan to: 1) synthesize and curate information resources for Puerto
Ricans on CVD prevention and treatment strategies and outcomes; 2) develop information resources for
improved information sharing to this population and their healthcare providers; and 3) ensure meaningful use
and dissemination of these information resources through a multisector collaborative research network
grounded in the principles of community-engaged research. First, we will develop multi-user health information
resources tailored to Puerto Rican communities, their healthcare providers, and librarians. Second, we will
adapt the Health Information Resource Equity architecture (HIRE), which leverages the existing SciCrunch®-
Disco® informatics platform, a cooperative and collaborative data and resource discovery platform for scientific
communities organized around diseases. The goal of the proposed HIRE architecture is to create an
informatics framework for a population-centered, not disease-centered, information resource for disparity
populations.

Public health relevance
NARRATIVE Accessing relevant scientific evidence on assessing CVD risk strategies on multiracial populations is difficult, since current terminologies about these populations used to index scientific literature are antiquated and not precise. The goal of this proposal “Accelerating Health Information Resource Equity for Multiracial Populations” is to harness the methods of library and information science, health disparities, and informatics research to improve access to and increase dissemination of information resources on CVD risk for multiracial populations and their healthcare providers.